How nursing staff skill mix, education and experience modify patient acuity-based estimates of required unit staffing

A significant body of literature demonstrates that the amount of nurse staffing, as well as the mix, available to
provide care to patients has an effect on patient outcomes. This relationship is present across multiple health
care systems, and has been shown to correlate with a number of different medical outcomes. While these
findings have impacted practice and policy, most studies of the relationship between nurse staffing and patient
outcomes are still conducted at the level of the entire hospital, which averages patient outcomes across a wide
variety of staffing levels. Detail at the unit level is essential to understanding the impact of nurse staffing
variability, and to designing effective interventions. In one of the few studies assessing staffing at the unit and
shift level over time, and using the difference between staffing targets and actual staffing over time, the gap
was significantly associated with differences in patient mortality. Such a measure of nurse staffing allows
organizations to set staffing target based on patient, unit, and organizational context, and design appropriate
staffing interventions while still providing a comparable staffing metric.
Health care systems struggle to define recommended or targeted levels of staffing. In response to national
concerns about system practices that impact patient outcomes, the VA Office of Nursing Services (ONS)
promulgated a Staffing Methodology (SM) directive in 2010, requiring the use of unit and facility level review of
staffing and patient data to formulate custom recommendations for target staffing levels on each shift. The
proposed study fills a gap in our understanding of how levels of nurse staffing affect patient outcomes.
Variation in nurse staffing level persists at both the facility and unit level. It is not clear, however, how changes
in staffing hours and staff mix at the unit level within facilities affect outcomes for patients. Critical questions
about the type and quantity of nursing hours actually delivered to patients are not known, nor is the effect of
variability in the gap between target and actual known. This project will use regression models to extend the
current knowledge of how nurse staffing affects patient outcomes (mortality, failure to rescue, infections related
to catheters, and risk-adjusted length of stay) with two major objectives.
Aim One: Use the extensive VA data systems to conduct the most rigorous study to date on how nurse
staffing levels and nurse affect patient outcomes. This will be the first large-scale examination of how shift-
level staffing affects patient outcomes, AND the first large-scale study to simultaneously use unit-level data
with controls for staffing levels, characteristics of the nurses, extensive patient risk-adjustment, and control
for use of other health care staff, including physicians. We will examine the gap between targeted and actual
nursing hours for each shift for the 66 VA facilities that use the AcuStaf nurse staffing program. We will also assess
whether shift-to-shift variations in the characteristics of the nursing staff modify the impact of differences between
targeted and actual hours.
Aim Two: Carefully test the robustness of findings to alternative empirical specifications, levels of
data aggregation, and inclusion of specific types of variables.
Our goal is to significantly improve our understanding of how nurse staffing impacts the outcomes of inpatient
care for Veterans. We will provide much more detailed data than is currently available on how nurse staffing
affects patient outcomes. These results will extend beyond VA as they will represent the most definitive study
of nurse staffing and patient outcomes to date, giving VA the best evidence available about how to make
staffing decisions. These results will inform the VA Staffing Methodology to help insure that each shift is
adequately staffed, with the expectation that appropriate nurse staffing will yield better patient outcomes. To
facilitate dissemination, we will work with ONS to create presentations of the results, including clear
presentations of how changes in nurse staffing (and the associated nursing costs) affect patient outcome.

Public health relevance
Over 700,000 Veterans are annually admitted to one of over 120 VHA hospitals providing inpatient acute medical-surgical, psychiatric and long-term care. The over 98,000 VA nursing personnel are a vital part of inpatient services. A significant body of literature demonstrates that the amount of nurse staffing available to provide care to patients has an effect on patient outcomes. The study we propose fills a gap in our understanding of system level decisions on patient outcomes, specifically focusing on how shift-to-shift gaps between the number of nurses needed on a shift and the available nursing staff affects patient outcomes, with controls for the characteristics of the nurses (e.g., education and experience) and patient risk. We believe that the extensive VA data systems will allow us to conduct the most definitive study to date on this topic.